HYPOXIA MARKERS WITH CELL PROLIFERATION MARKERS IN HUMAN TUMORS

The current proposal utilizing Pimonidazole represents another step in the ongoing hypoxia marker studies, similar to our previous protocol CRU 767 desscribing the use of misonidazole as a tumor hypoxia marker. Pimonidazole will be administered intravenously.